Mechanisms of mechanotransduction during neural tube morphogenesis

Actomyosin contractility is a central regulator of cell polarity, cell shape and tissue mechanics in development,
physiology and disease. Dysregulation of actomyosin organization can lead to cancer and birth defects, such as
neural tube defects (NTD), heart defects and hereditary deafness. Thus, understanding how actomyosin
contractility generates both the physical forces and mechanosensitive signaling to coordinate cell behaviors is
of both fundamental and medical importance. The conserved Planar Cell Polarity (PCP) pathway has been
implicated in mechano-sensing and orientation of cell polarity within the tissue plane during vertebrate tissue
morphogenesis. In addition, our work has identified an essential, parallel PCP signaling pathway mediated by
Ptk7, a pseudo-receptor tyrosine kinase (RTK) that lacks kinase activity. Live imaging of neural convergent
extension movements in mouse embryos has revealed that, while core PCP pathway components regulate apical
junction remodeling, Ptk7 is required for planar polarization of neural plate cells during neural tube
morphogenesis. Ptk7 signals to Src family kinases (SFKs) to modulate actomyosin contractility at epithelial cell
contacts. However, the signal transduction mechanisms by which Ptk7 controls planar polarity are poorly
understood. To fill this significant knowledge gap, we will use multidisciplinary approaches combining
biochemistry, mouse genetics, including a CRISPR-generated Ptk7 allelic series, and fluorescence imaging of
cytoskeletal, junction and Rho GTPase signaling dynamics in neural plate cells in intact live mouse embryos.
Based on a strong foundation of preliminary data, Aim 1 will test the hypothesis that Ptk7 imparts planar polarity
through RTK-like conformational changes, using conformation-specific anti-Ptk7 antibodies, PCP signaling
assays, and Ptk7 knockin mouse mutants carrying human NTD-associated variants or predicted allosteric
mutations. Aims 2 and 3 will test whether the cell polarity protein Par3, a junction-associated Angiomotin-Merlin
complex, and the transcription factors Yap1/Taz mediate mechanotransduction in the developing neural tube
downstream of Ptk7, using conditional mouse mutants, PCP signaling assays and live imaging of cellular and
cytoskeletal dynamics. By correlating neural tube, cytoskeletal and cell behavior defects in these mutants, we
will be able to tease apart the contributions of distinct cellular and molecular mechanisms, including apical
junction remodeling, polarized basal protrusive activities and apical constriction of neural epithelial cells, to the
complex process of neural tube formation.
A long-term objective of this work is to gain a mechanistic understanding of how cells integrate actomyosin
contractility and intra- and inter-cellular signaling in space and time during neural tube morphogenesis. In
addition, the proposed work will generate new insights into mechanisms of action of pseudo-RTKs and the
etiology of human neural tube defects.

Public health relevance
PROJECT NARRATIVE Dysregulation of the actin and myosin network can profoundly disrupt how cells respond to their environment and communicate with one another, leading to cancer and birth defects, such as neural tube defects and hereditary deafness. The proposed work will advance our understanding of how actin and myosin networks influence cell-cell communications essential for tissue assembly. Ultimately, this new knowledge will facilitate diagnosis and treatment of human birth defects and help improve the health and quality of life by restoring, maintaining, or enhancing tissue and organ function.